Core-002

Core C: Bioinformatics and Data Management Core Summary The Bioinformatics and Data Management Core (BDMC) will provide data analysis and management services for the full AADCRC Center Entitled “Epithelial Immune Responses During Respiratory Viral Exacerbation of Asthma”. This BDMC will serve both Research Projects, receiving demographic and clinical data from each Project and high quality -omics data from the Benaroya Research Institute genomics core. The BDMC will ensure a unified approach to experimental design and analysis for all projects, be responsible for the flow of data and information across all components of the Center, and be responsible for the submission of completed data sets/projects to ImmPort, GEO, and other public archives. To meet these goals, the BDMC will leverage existing infrastructure and expertise that exist at the University of Washington and Benaroya Research Institute. The BDMC has three Specific Aims: In Specific Aim 1, the BDMC will provide analysis services and consultation for the aims on each of the two Projects. In Specific Aim 2, the BDMC will provide central storage, management and information security for data generated by the Center. In Specific Aim 3, the BDMC will coordinate the timely submission of Center data sets to ImmPort and other repositories, according to the NIAID standards. Data will be submitted in conformance with existing format standards and meta-data annotation standards to facilitate integration with data from other investigators and with ImmPort tools for data retrieval, visualization, and analysis. The key impactful features of the BDMC are the processing, tracking, and storage of Center data, the presentation of actionable information in the process of completing both Research Projects, and critically, the transformation of Center data into information and interpretation via analysis.